Elastic exosome-releasing conductive patches for heart repair

Project summary
Myocardial infarction (MI) remains a leading cause of morbidity and mortality in the United States and worldwide.
Besides cell-based cardiac therapy, the cell-free biodegradable cardiac patch is an appropriate alternative to
treat MI and has been determined to restore heart function along with increased wall thickness and angiogenesis
as well as reduced scar area. However, the MI-induced scar tissue is non-conductive due to cardiomyocyte
death, which lacks electrical integration with surrounding native tissue and cannot electrically couple with viable
cardiomyocytes in the infarcted tissue. The conventional cardiac patches are non-conductive, which cannot
address such issues. Thus, our goal in this project is to develop a new conductive cardiac patch with good
biosafety and bioactivity to promote heart function restoration. Recently, conductive biomaterials have been
utilized to manage heart infarction in vivo, which increased conductive induction and electrical coupling along
with increased angiogenesis and reduced scar size without pathologic arrhythmias, compared to the
conventional non-conductive patches. Current conductive biomaterials are composites from biodegradable
polymers and nondegradable conductive polymers (such as polyaniline and polypyrrole with dopant) or nano-
scale additives (such as gold nanorod, carbon nanotube, and graphene oxide), which have several concerns in
biodegradation, processability, toxicity, and conductivity stability. To address such concerns, our group has
developed a fully degradable, elastic, and conductive polyurethane, which does not require to add the extra
dopant. It has good biocompatibility and conductivity stability and supports cardiomyocyte growth in vitro.
Additionally, the exosomes secreted from primary cells and stem cells have been evidenced to significantly
restore heart function with improved angiogenesis and reduced fibrosis and scar size after being delivered into
the infarcted heart. Thus, we hypothesize that a combination of fully biodegradable conductive elastic patch and
cardiac stromal cell-derived exosome will show synergistic effects on heart function restoration. Furthermore, to
reduce the risks of open-chest surgery for patch implantation and enhance the translation of the developed
cardiac patches, a minimally invasive approach is developed to deliver the biohybrid patch on the infarcted heart.
To reach the goal, three aims are proposed. Aim 1 is to optimize and comprehensively characterize the
biodegradable conductive porous polyurethane patch; Aim 2 is to develop the biohybrid scaffolds of combining
elastic conductive cardiac patch and cardiac stromal cell-derived exosome and assess their therapeutic efficacy
in rat infarction model; and Aim 3 is to evaluate their efficacy of the biohybrid scaffolds in a clinically relevant pig
model. The project is innovative and translational. The unicomponent biodegradable conductive polyurethane
without adding extra dopant is novel, combining the conductive cardiac patch with exosome is innovative to offer
synergistic effects, and the minimally invasive implantation is promising to reduce the open-chest surgery risks.

Public health relevance
Project Narrative Myocardial infarction is a fatal problem in the United States and is potentially managed using a biodegradable cardiac patch with open-chest surgery. We will develop a novel biohybrid patch from biodegradable conductive elastic scaffolds and cardiac stromal cell-derived exosomes to enhance heart function restoration through minimally invasive implantation. If successful, this novel cardiac patch would exhibit synergistic effects to significantly promote heart function restoration.